Targeting Collagen Mechanical Damage using Collagen Hybridizing Peptides

SUMMARY
Detection of Collagen Mechanical Damage using Collagen Hybridizing Peptides.
Mechanical injury to load-bearing tissues leads to many clinically significant conditions (e.g. tendinosis, rotator
cuff disease) but we have limited understanding of the injury process of tissues that are damaged by mechanical
stress. The overall goal of the proposed research is to gain new understanding of the biomechanics of load
bearing collagenous tissues by developing the collagen hybridizing peptide (CHP) technology into a new
mechanical damage detection method. CHP has been reported to bind to denatured collagen strands originating
from protease activity or by mechanical damage in a manner similar to primer binding to melted DNA during
PCR. We propose to substantially expand the capabilities of CHP damage detection by developing new CHPs
that are smaller for faster diffusion into dense musculoskeletal tissues and exhibit accelerated binding kinetics to
allow faster damage reporting. We will also develop a new CHP that only fluoresces upon binding with collagen,
eliminating the need to stain and wash tissues and enabling the CHP to serve as a damage gauge in overloaded
tissues. We will then develop optimized protocols for the use of the existing and new CHPs, determine the
relationship between collagen fibril strain and CHP binding in musculoskeletal soft tissues, and quantitatively
compare CHP targeting to other techniques. Finally, we will apply CHP targeting to elucidate the relationship
between tissue level mechanical loading and mechanical damage to collagen at the molecular level. We will
focus on two important musculoskeletal tissues of considerable clinical relevance: tendons and articular
cartilage. Considering the wide-spread impact of collagen damage in musculoskeletal injuries and diseases, in-
depth understanding of the relationships between molecular level collagen damage and mechanical overloading
will provide new insights into the biomechanics of load-bearing tissues as well as help develop new diagnostics
and therapies for managing musculoskeletal disorders.

Public health relevance
PROJECT NARRATIVE Detection of Collagen Mechanical Damage using Collagen Hybridizing Peptides. The proposed work will develop new and improved peptide-based probes that can hybridize to mechanically damaged collagen with high efficiency; these probes will be used to elucidate the mechanisms of stress-induced injury in tendon and articular cartilage. Fibrous collagen is the major component of almost every load-bearing tissue, and molecular-level collagen damage is associated with permanent mechanical damage in those tissues. The outcome of this research will help manage common musculoskeletal injuries and disorders by deepening our understanding of mechanical damage in tissues and by identifying opportunities for new diagnostics and therapies.